A Data-Driven Approach to Chiroptical Sensor Development

Project Summary/Abstract
The synthesis of stereochemically defined small molecules is tremendously important to solving biological
problems, especially in identifying medicines for disease treatment. In many cases, the stereochemical
information contained in a natural product or pharmaceutical compound is critical in determining its biological
activity. Due to this general importance, innovative methods to rapidly determine molecular stereochemistry and
stereoenrichment would be impactful. To this end, several research groups have recently reported
stereochemical sensing assemblies that may assay enantiomeric excess (ee) using only spectroscopic methods
(circular dichroism (CD), UV-Vis, and fluorescence). Most of these reports, however, are limited to the analysis
of stereocenters α to the functional group that binds to the sensing motif and more remote stereocenters ( β, γ,
δ, etc.) remain challenging to identify. To address this need, this proposal seeks to utilize data-driven
methodologies to rationally design sensing assemblies capable of quantifying the ee of γ-stereogenic alcohols
using only CD spectroscopy. These methodologies have been previously shown to effectively optimize chemical
reactivity, but their use in chemical sensing has not yet been realized. While the proposed studies focus
specifically on γ-stereogenic alcohols, it is anticipated that the workflows and design principles developed herein
will be easily translated for further applications of optical stereochemical sensing.

Public health relevance
Project Narrative The stereoselective construction of organic small molecules is of utmost importance to the pharmaceutical and fine chemical industries. As such, methods to rapidly quantify stereoenrichment are highly valuable. To address this important issue, this proposal seeks to utilize data-driven methods to rationally design sensor assemblies capable of quantifying the enantiomeric excess of a historically challenging substrate class: γ-stereogenic alcohols.